GENETICS OF NATURAL KILLER ACTIVITY IN MAN

We have examined the influence of homozygosity at HLA loci on Natural Killer (NK) cell activity on the distribution of target binding cells (TBC) and subset of NK cells (CD16+ Leu19+) in normal genotyped unrelated individuals and in families. Homozygous cells have low NK activity compared to heterozygous donors. This low cytotoxic activity had no correlation with sex, but did correlate with homozygosity at the HLA-A,B,C and/or DR loci. Although at the population level the mean frequency of TBC and CD16+ Leu19+ cells were not different in these two groups, the frequency of Leu19+ cells was significantly lower in homozygous, and the majority of homozygotes belong to the HLA composed of alleles in linkages disequilibrium. The specific aims of this proposal is to extend these studies on the determination of (1) NK cell activity, (2) TBC and (3) NK surface phenotypes on an extended panel of genotyped unrelated donors and families. Family data will be analyzed for linkage and mode of inheritance. Using monoclonal antibodies anti- Leu7, anti-CD16, anti-Leu19 and anti-CD3m and cell sorter determine the mechanism responsible for low cytotoxic activity of homozygous/heterozygous low responders. We will test the hypothesis that low responders have fewer cytotoxic NK cells, and that the level of cytotoxiity is controlled by genes linked to HLA- A, B, C and/or DR. loci. The long term goal is to study the existence of HLA linked genes controlling the level of NK activity in humans and to understand its function.